PATTERNS OF DRUG USE AMONG THE ELDERLY

Analysis of prescription and over-the-counter drug data that have been collected by the four contracts that comprise the Established Populations for Epidemiologic Studies of the Elderly (EPESE) will be supported by an interagency transfer of funds. The existing contracts will be supplemented to focus on such analyses.